HEART Study: Development of the Health Equitability Assessment and Readiness Tool

PROJECT SUMMARY
Even though highly efficacious biomedical prevention and treatment interventions exist for a range of infectious
diseases, implementation has been marred by pervasive and unacceptable racialized disparities and led to
inequitable population health effects. While public health increasingly recognizes health equity as a priority, at
present we lack — and urgently need — a scientifically grounded, empirically supported, tool to assess the
equity capacity or equitability of public health programming and implementation. Such an instrument would
enable researchers, practitioners, and policymakers to advance equitable outcomes through anticipating gaps
before they occur, direct context-specific capacities, target improvements and resources and thereby
accelerate progress toward health equity. The Health Equitability Assessment and Readiness Tool (HEART)
will address this significant gap by completing the following specific aims 1) use a formal set of mixed method
activities to support the conceptual development and concept mapping of equitability into measurable domains,
2) develop the content, structure, and design of the HEART measure and conduct preliminary psychometric
analysis to assess validity and internal reliability, and 3) to implement and evaluate HEART in various HIV
program settings. The expected outcome is a scientifically validated and practical measure of public health
program’s equitability that can be easily integrated in community and clinical settings. The principal investigator
is well-positioned to lead the study activities with the support of her established team of collaborators with
complementary expertise in infectious disease prevention, health equity, implementation science, and
measurement development. The proposed project is in alignment with the New Innovator’s Award’s mission to
support “risky…innovative and high impact research concepts that will advance key concepts on broad,
important problems in biomedical research.”

Public health relevance
PROJECT NARRATIVE Health equity is a public health priority and key outcome of the federal initiative to end the HIV epidemic. However, public health professionals lack tools to assess the ability of a given program to produce equitable outcomes. This research will not only address this gap but also make a significant contribution to the public health and health equity landscape through the development of the Health Equitability Assessment and Readiness Tool (HEART). The HEART will be a valid and practical tool used to assess the equitability of public health programs.